Engineering and Characterization of pH dependent Antibodies

Project Summary
Engineering and Characterization of pH dependent Antibodies
Antibody-antigen interactions have served as a prototypical model for better understanding
protein-protein interactions and protein design, as well as serving a vital role in life science
applications. Such antibodies are indispensable to a wide range of fields including cell and
molecular biology, molecular imaging, diagnostics, nanotechnology, and next generation
antibody therapeutics. While the goal of antibody engineering is most often focused on
achieving high affinity or stability, over the last several years, the Horn lab has explored new
directions in the design of protein interactions, namely the introduction of linked equilibria that
may be used to control (or regulate) antibody/antigen interactions. These efforts successfully
produced antibody variants with gain-of-function pH switches, allowing the protein interaction to
be modulated over a range in pH. This proposal aims to explore a new direction on these efforts
by investigating methods control VHH and Fab antibody interactions through the introduction of
acidic residues in the interface. This research has the potential to open new opportunities in
how antibodies may be used in therapy. Given the wide-spread use of antibodies in applications
where pH-based control provides functional advantages, the outcomes of this work are likely to
be wide interest.

Public health relevance
Project Narrative Antibodies play a vital and growing role in life science applications, such as protein therapeutics. The research described in this proposal is designed to explore new methods to generate pH dependent antibodies. The relevance of this project to public health is two-fold: (1) it will provide new opportunities for the use of antibodies to preferentially target certain microenvironments, such as that found in cancerous tumors, and (2) it will provide fundamental insight towards the development and novel use of protein reagents for life science applications.